Molecular Mechanism of HIV Entry Mediated by Chemokine Receptor CCR5

DESCRIPTION (provided by applicant): This proposal Molecular Mechanism of HIV Entry Mediated by Chemokine Receptor CCR5 is focused on X-ray structure determination of complexes between chemokine receptor CCR5, an HIV entry co- receptor, and a variety of ligands including peptidomimetics. The ultimate goal is to use the experimentally determined structure to carry out drug discovery aimed at inhibiting HIV cell entry using structure-based drug design (SBDD) approaches. CCR5 is the primary co-receptor responsible for HIV transmission, while emergence of CXCR4-tropic (X4-tropic) viruses later in infection correlates with a more rapid CD4 decline and a faster progression to AIDS. As the predominant co-receptor for HIV entry, CCR5 has long been taken as one of the most important drug targets. Five CCR5 targeted drugs to date have been brought to clinical trial, but only one, Maraviroc, has been approved by FDA. Molecular details of how this drug as well as other CCR5 cell entry inhibitors works are not understood and will be a focus of the proposed study. The proposed structural studies will be carried out using methods and approaches of the Gene-to-Structure-Pipeline that was developed by the GPCR Network. The specific aims are: 1) Optimize the CCR5 construct design to generate large samples of highly purified and thermally stabilized CCR5 for biophysical and functional studies; 2) Design and synthesize chemical tools that can be used to stabilize CCR5 and to probe ligand-receptor interactions; 3) Develop an understanding of CCR5 ligand binding properties by determining the 3D structures of several complexes. It is expected that structural knowledge generated by our studies will lead to the development of new therapeutic strategies and help in stopping the growth of the HIV/AIDS epidemic in China and elsewhere in the world. PUBLIC HEALTH RELEVANCE: The proposed project attempts to understand the ligand binding properties of the HIV co- receptor CCR5. Studies will then focus on using this knowledge to develop new therapeutic strategies against the virus with the expectation that this will help in combating the Global HIV/AIDS epidemic.

Public health relevance
The proposed project attempts to understand the ligand binding properties of the HIV co- receptor CCR5. Studies will then focus on using this knowledge to develop new therapeutic strategies against the virus with the expectation that this will help in combating the Global HIV/AIDS epidemic.